ISMRM Workshop on Perfusion MRI: From Head to Toe

Project Summary/Abstract:
We propose to hold an International Society for Magnetic Resonance in Medicine (ISMRM) Workshop
entitled “Perfusion MRI: from head to toe”, in February 2022 in Los Angeles, California. Perfusion MRI provides
important diagnostic biomarkers in many diseases throughout the body, beyond those available from standard
anatomic MRI. The significance of Perfusion MRI has been extended to virtually all specialties of medicine.
Notably, the last Perfusion workshop was held in 2012, approximately ten years ago by the time of the
proposed workshop. Therefore, we believe that the 2022 Perfusion Workshop will not only be a much-
anticipated event to scientists and clinician in the ISMRM, but will also be of great interest to the clinical
community, such as neurology, psychiatry, oncology, cardiology, nephrology, pulmonology, hematology, and
orthopedics.
The purpose of the proposed ISMRM Perfusion MRI Workshop is to bring together scientists and clinicians
interested in technical research and application-oriented innovations in perfusion MRI. The Workshop has two
aims. Aim 1 is to organize an interdisciplinary international workshop highlighting the opportunities and
challenges of perfusion MRI and its clinical applications. Aim 2 is to discuss the key questions and gaps in the
Perfusion MRI field to guide future research in the field.
The organizing committee consists of a diverse group of scientists and clinicians with inclusions of women
and underrepresented minority as well as a mixture of junior and senior investigators. A diverse panel of world-
renowned scientists and clinicians will present their research in methodologies and applications of perfusion
MRI. Childcare facilities and disability access will be available to the attendees. The Workshop will be CME-
accredited. The Workshop will employ several novel approaches. Scientific presentations will be combined with
new socializing and networking methods to provide ample opportunities of discussion, collaboration, and brain-
storming. To lower registration fee and make trainee attendance affordable, we will hold the Workshop at a
University campus with free use of conference venue. To maximize the impact of the Workshop on the
scientific community and to move the perfusion MRI field forward, we will set concrete goals with outcomes
including 4 consensus papers and an open-source initiative statement. While we anticipate to be able to hold
the Workshop for in-person attendance, we also plan to use a hybrid registration format where attendees have
the option to attend the Workshop virtually.
Therefore, the 2022 Perfusion MRI Workshop will be a timely event to unify and further publicize recent
efforts in perfusion MRI, and is expected to set a milestone for broader clinical applications of perfusion MRI in
the era of personalized medicine.

Public health relevance
Project Narrative We propose to hold an International Society for Magnetic Resonance in Medicine (ISMRM) Workshop entitled “Perfusion MRI: from head to toe”, in February 2022 in Los Angeles, California. Perfusion MRI provides important diagnostic biomarkers in many diseases throughout the body. The proposed Workshop will set a milestone for broader applications of perfusion MRI in clinical disciplines such as neurology, psychiatry, oncology, cardiology, nephrology, pulmonology, hematology, and orthopedics.